CHAIRS-C: Climate, Health, and Aging Innovation and Research Solutions for Communities

The Administrative Core of CHAIRS-C will be responsible for synthesizing findings from the Research,
Community Engagement, and Capacity Building Cores into actionable solutions to mitigate the health threats
for older adults in the face of climate change, particularly increasing heat and pollution effects. This Core will
serve as the central organizing Core of CHAIRS-C, ensuring the oversight, coordination, and integration of
activities across the other cores, and establishing and maintaining effective collaborations within Brown
University and with external community partners. The leadership of the Administrative Core will provide
oversight of grant finances and annual reporting requirements; participate in the Research Coordinating Center
activities; solicit and mentor new grant applications designed to expand and sustain the Center’s research on
climate change and aging; advance an effective data infrastructure for partners; evaluate the productivity of
cores and their success in achieving diversity and inclusion goals; and serve in other administrative roles that
arise over the course of the P20. To achieve these long-term objectives, the Administrative Core has identified
the following specific aims: 1) Integrating the goals and outcomes from the CHAIRS-C Cores to advance
science on the adverse health implications of climate events and develop actionable solutions to promote
healthy aging; 2) Accelerating the science of climate change and healthy aging with guidance from
transdisciplinary leaders in the community, on campus, and from national experts; 3) Establishing a biomedical
and environmental data infrastructure that will support partnerships with communities, researchers, and policy
makers; and 4) Fostering sustainability through new research grants, including a future Center of Excellence.